Alaska Indigenous Research Program

Project Abstract
The goal of the proposed collaborative Capacity Building Project between the Alaska Native Tribal Health
Consortium (ANTHC) and Alaska Pacific University (APU) is to increase capacity for conducting culturally
responsive and respectful health research that addresses the unique setting and health needs of AN/AI
Peoples. The objective is to continue the momentum of the NARCH X funded Alaska-based research training
and education program “Alaska Indigenous Research Program” (AKIRP) in building a network of Indigenous
and non-indigenous students, researchers and health professionals and scientists. The AKIRP is innovative
and unique in that it differs from conventional approaches to cultural competency education and training by
bringing together diverse perspectives and epistemologies - Indigenous and Western worldviews and ways of
knowing - in an effort for mutual understanding, reciprocity, respect and the co-production of solutions that
address health disparities among AN/AI Peoples. This is known as “Two-Eyed Seeing” or “Etuaptmumk”, a
framework that was first proposed by Mi’kmaw Elders Albert and Murdena Marshall as a way to bridge
Western science and Indigenous knowledge. The AKIRP aims to 1) provide Indigenous-centered cross-cultural
health research education and training, 2) offer internship and mentorship opportunities and 3) providing career
development support and research guidance and consultation. Continuing the AKIRP contributes to the overall
goal of the ANTHC NARCH XII to conduct tribally-driven health research in pursuit of ANTHC’s vision that
Alaska Native people are the healthiest people in the world. The expected long-term outcomes are new and
improved ways of conducting research in collaboration with Indigenous peoples and communities to find
solutions to health disparities and inequities that have not been addressed successfully before.